ERβ repurposes EZH2 to suppress oncogenic NFκB signaling in TNBC

PROJECT SUMMARY/ABSTRACT
Breast cancer remains the most commonly diagnosed cancer in women and is the second leading cause of
cancer-related deaths among women. Triple Negative Breast Cancer (TNBC) affects approximately 15-20% of
all breast cancer patients, is the most aggressive sub-type of breast cancer and accounts for a
disproportionately higher fraction of cancer-related morbidities and mortalities. Treatment options are
extremely limited for TNBC patients and the most commonly employed neoadjuvant and adjuvant
chemotherapy drugs have existed for decades. De novo and acquired chemotherapy resistance remains a
major problem and disease recurrence results in breast cancer-related death for the large majority of patients.
Further complicating the clinical management of TNBC is the lack of FDA-approved targeted therapies that can
be utilized to prevent disease recurrence in the adjuvant setting. Thus, the identification and validation of novel
drug targets and more effective treatment options continues to represent a major unmet clinical need. We have
demonstrated that Estrogen Receptor Beta (ERβ) is expressed in approximately 20% of TNBCs, and have
shown that patients with ERβ positive tumors have improved long-term prognosis. In addition, we have shown
that ligand-mediated activation of ERβ by estradiol, or ERβ selective agonists, inhibits TNBC cell line and
patient derived xenograft proliferation, invasion, and migration in vitro, as well as primary tumor growth and
metastatic spread in vivo. Importantly, we provide the first evidence that estradiol can elicit clinical benefit in a
patient with ERβ positive metastatic and chemo-refractory TNBC. Mechanistically, we demonstrate that ERβ
potently suppresses the nuclear factor kappa B (NFκB) pathway in TNBC cells, effects that are mediated
through association of ERβ with EZH2/PRC2 leading to epigenetic modifications to histone residues at NFκB
target gene loci. Furthermore, we have demonstrated that ERβ modifies chemotherapy responsiveness of
TNBC cell line models and patient derived organoids and inhibits chemo-resistant cell lines. Based on these
data, the central hypothesis of this proposal is that ERβ repurposes EZH2 to inhibit NFκB signaling in TNBC
thereby eliciting anti-cancer effects and enhancing chemotherapeutic responsiveness. To test this hypothesis,
the following Specific Aims are proposed: 1). Determine the molecular mechanisms by which ERβ suppresses
NFκB signaling in TNBC and 2). Elucidate the biological importance and clinical significance of ERβ-mediated
suppression of NFκB signaling in TNBC using novel genetically engineered mice, PDX/PDO models and
patient specimens. To conduct these Aims, we will utilize multiple model systems, innovative approaches and
molecular tools, to comprehensively address our focused hypothesis. Given the extremely poor outcomes in
women with TNBC, the proposed studies are of critical importance towards the goal of improving treatment
strategies to more effectively manage this disease.

Public health relevance
PROJECT NARRATIVE Triple negative breast cancer (TNBC) is an aggressive form of the disease with few treatment options, high recurrence rates and disproportionately higher mortality rates. This proposal involves elucidating the mechanisms by which estrogen receptor beta (ERβ) elicits potent anti-cancer effects in TNBC and determining the utility of specifically targeting this receptor, alone and in combination with established chemotherapy regimens, for therapeutic purposes. Results of the proposed study are expected to contribute to the development of a new class of therapies, and allow for better stratification of patients to specific forms of chemotherapy, ultimately resulting in improved outcomes for thousands of patients each year.